Task A1B1C1D1: Vaccine and Treatment Evaluation Units: Shigella Clinical Trial for a Shigella Vaccine Candidate

This program is comprised of a consortium of individual contracts within academic centers and organizations that provide a ready resource for the design and conduct of clinical trials to evaluate promising products to combat infectious diseases. In general, products will be evaluated in normal healthy populations; however, access to special populations is also available. This trial supports the evaluation of a Shigella vaccine candidate.